The Role of Ovarian Hormones in Regulating Dopamine Acetylcholine Interactions in the Nucleus Accumbens

Abstract
There are reported sex differences in both the propensity to develop nicotine addiction and the efficacy
of treatment interventions pointing to women as a particularly vulnerable population. Thus, understanding how
sex differences in nicotine effects on the brain arise is a critical unanswered question in addiction
neuroscience. Dopamine signaling within the nucleus accumbens is involved in initiation and maintenance of
nicotine addiction, and dopamine release is sensitive to heavy modulation by acetylcholine through nicotinic
receptors located on dopamine axons. Acetylcholine modulation of dopamine release at distal axon terminals
is discussed extensively, and better understanding this interaction has driven experimentation across fields -
critically, we find that this interaction is not present in adult intact females. However, our preliminary data show
that this effect is rescued in females after ovariectomy, suggesting that ovarian hormones play a critical role
in modulating acetylcholine effects on dopamine release; the goal of this proposal is to define where
this modulation occurs and how this influences nicotine effects on this system.
This proposal is guided by the overarching hypothesis that estradiol acts acutely through estrogen
receptors located within acetylcholine interneurons in the nucleus accumbens core to strengthen acetylcholine
effects on dopamine release. However, in intact females, long-term estrogen modulation of this interaction
leads to an inability of modulators – such as nicotine – to further enhance dopamine release. This is supported
by robust preliminary data showing that in males and ovariectomized females estradiol effects on dopamine
release can be blocked via nicotinic receptor antagonism. In intact females, estradiol effects on dopamine
release are blunted and insensitive to nicotinic receptor agonists and antagonists.
This fellowship application describes a robust training plan to investigate the microcircuitry of how
ovarian hormones mediate dopamine-acetylcholine interactions and the role that this plays in attributing
motivational value to nicotine-associated cues. Aim 1 will define the estrogen receptor subtypes contributing to
estrogen effects on acetylcholine-dopamine interactions. Aim 2 will determine how estrogen receptors regulate
acetylcholine release using optical acetylcholine sensors. Aim 3 will use genetic approaches to knock out
estrogen receptors from acetylcholine interneurons and determine how this affects the ability of dopamine to
respond to nicotine and nicotine-associated cues in operant tasks. This plan expands on my current
electrophysiology expertise to train me on optogenetic tools and optical imaging and gives me the career
development opportunities necessary to propel me to a successful placement in a tenure-track position at a
respected institution. Together, the results of this project will critically inform the addiction field on the effects of
ovarian hormones on dopamine interactions in the nucleus accumbens core, providing new directions for more
effective treatment of addiction.
.

Public health relevance
Project Narrative: Sex differences in nicotine effects combined with blunted responses to treatment approaches combine to lead to worse treatment outcomes for nicotine addiction in women. Nicotine acts through hijacking endogenous acetylcholine signaling, which ultimately leads to the increases in dopamine release that drive nicotine reinforcement. This grant focuses on outlining how ovarian hormones contribute to sex differences in dopamine release regulation by acetylcholine in female subjects, and will provide a better understanding for pharmacotherapeutic approaches for nicotine treatment in women.